Examination of a drinking to cope pathway: Comparisons between Latine, Black and White young adults

Project Summary
Previous studies show that Black and Latine individuals experience alcohol-related problems at
higher rates than White individuals. Research investigating the driving mechanisms that
contribute to these inequities is nascent. Within predominately White samples, differential
response to alcohol, stress, and coping motives (drinking to cope with stress/negative mood) have
been studied as separate risk factors. The proposed supplement falls within the scope of the
ongoing R01 by identifying the structural and social determinants of inequities in alcohol problems
for Black (R01) and Latine (supplement) individuals. The proposed research will elucidate both
common and unique experiences for minoritized racial and ethnic populations that experience
high levels of structural and interpersonal discrimination and downstream stress exposures. The
proposed supplement will utilize the R01 procedures and existing infrastructure: a within-subjects
lab-based alcohol administration and a 17-day ecological momentary assessment period to
examine alcohol response, discrimination, stress, drinking motives, and alcohol use and
problems. This project will be the first to examine the anxiolytic effects of alcohol in relation to
coping motives and ultimately alcohol-related problems for Latine individuals. The proposed
supplement accomplishes the NIH goal of promoting diversity in health-related research by
providing the candidate opportunities for comprehensive training in health equity and alcohol
research. The candidate’s training will consist of the following components that will best prepare
her for the next step in her process of attending graduate school: conceptual knowledge of alcohol
research and inequities in alcohol problems, applied alcohol research skills, understanding of
health equity research through existing literature and community-engaged approaches (bimonthly
community partnership meetings), and professional development. These components of the
mentoring plan will be accomplished through individual weekly meetings, directed readings,
weekly lab meetings, biweekly journal clubs, conference attendance and presentations, monthly
meetings with an internal consultant with expertise in Latine health and acculturation processes,
and monthly seminars. This proposed research supplement will provide the candidate
opportunities to expand her research skills in alcohol use, health equities, and engagement with
the Latine community, while simultaneously expanding upon the research currently being
conducted under the ongoing R01.

Public health relevance
Project Narrative Latine young adults engage in heavier alcohol use and experience more alcohol-related problems than White young adults, yet few studies have examined why these inequities exist. The proposed project tests a coping pathway that examines stress and discrimination exposure and sensitivity to the anxiolytic effects of alcohol inside the laboratory and in the natural environment, as contributors to increased alcohol use and problems in this minoritized group. Training and alcohol and health equity research will be provided as part of this supplement to candidate committed to pursuing a research career focused on reducing and eliminating health inequities in alcohol problems for minoritized populations.